Educational Modules to Broaden Academic Research Cultures (EMBARC)

Project Summary/Abstract
Although undergraduate research training programs have made progress in engaging underrepresented
minority (URM) students in biobehavioral science, disparities in the community college-to-university pipeline
remain given the focus has been on undergraduates at 4-year universities despite the fact that URM students
are more likely than non-URM students to enroll in and receive part of their training at a community college
(CC). The purpose of the proposed Educational Modules to Broaden Academic Research Cultures (EMBARC)
program is to invite, retain, and support transfer of CC students in the biobehavioral sciences through
innovative, culturally-informed educational modules, rigorously tested through a partnership with the largest
community college district and system of higher education in the country (Los Angeles Community College
District [LACCD], California Community Colleges Chancellor’s Office [CCCCO]) and distributed nationwide with
some of the largest professional organizations for URM students in biomedical and behavioral sciences
(Annual Biomedical Research Conference for Minority Students [ABRCMS], American Psychological
Association [APA], Society for Advancing Chicanos/Hispanics & Native Americans in Science [SACNAS]). We
accomplish this through the following specific aims: (1) Develop interactive educational modules using
qualitative (inductive, student-based) and quantitative (deductive, empirical and theory-based) approaches,
providing multiple formats (summer-intensive face-to-face [SI-FTF], annual-year face-to-face [AY-FTF]
facilitated by peer trainers in a Train-the-Trainer [TTT] model, or self-paced online [SP-O]) to maximize
accessibility for CC URM students with a variety of circumstances and needs; (2) Extensively test the
educational modules using experimental and control groups for each presentation format at 9 LACCD
campuses to ensure relevance and validity of the modules as accessible options that increase biobehavioral
self-efficacy, belonging, and transfer; (3) Establish and disseminate our modules through online repositories
designed for students, trainers, and institutions who can access and customize a menu of materials on
scientific skills and scripts that connect students’ passion and vision for their role in biobehavioral research;
and (4) Evaluate the effect of high impact practices, such as mentored conference travel and speaker series, to
strengthen professional networks and scientific belonging by creating access to role models and opportunities
for students to practice and maintain skills learned. EMBARC will result in rigorously-tested, culturally-relevant
training modules across multiple formats, a publicly-accessible repository with a suite of training and workshop
offerings, 99 trained CC facilitators, and the potential to impact 100,000+ students, scientists, and educators
interested in health research through our CC networks and professional organization partnerships.

Public health relevance
Project Narrative Educational Modules to Broaden Academic Research Cultures (EMBARC) is relevant to public health and the mission of NIH/NIGMS because it innovatively leverages cultural frameworks to train and promote transfer of underrepresented minority (URM) community college (CC) students to biobehavioral research career fields at an early and critical period of professional and scientific development. We anticipate EMBARC trainees will be equipped to succeed in biobehavioral research contexts and address the complex health needs of a rapidly diversifying U.S. population. Our approach includes rigorous testing of culturally-informed educational activities and modules through a partnership with the largest community college district within the largest system of higher education in the country (Los Angeles Community College District [LACCD], California Community Colleges Chancellor’s Office [CCCCO]) and distribution nationwide with some of the largest scientific organizations for URM students representing biobehavioral science (ABRCMS, APA, SACNAS) to maximize outreach and sustainability of our efforts to diversify the scientific workforce.